Neurocomputational Modeling Core

PROJECT SUMMARY
The overarching goal of the Neurocomputational Modeling Core is to provide a common formal framework
that can incorporate measures of neural activity, connectivity, and behavior across Projects 1-5 to (a) quantify
the functional roles of the OCDnet and its components in approach-avoidance decision-making and OCD
symptomatology, and (b) predict changes in decision-making dynamics and symptom severity as a result of
neural and clinical interventions. To achieve these goals, we will leverage (a) models of decision dynamics and
their modulation by neural activity within individual circuit nodes, and (b) graph-theoretic models of interactions
across circuit nodes. To quantify decision dynamics during the PAAT task, we will use hierarchical Bayesian
parameter estimation of the drift diffusion model (HDDM), which enables reliable estimation of decision
parameters and their modulation by trial-by-trial variance in neural signals, and supports Bayesian hypothesis
testing for how these parameters may differ as a function of clinical status and neuromodulation. We have
previously shown how such “computational biomarkers” can discriminate between patient conditions and
symptoms better than traditional measures of behavior and brain activity, including in an approach-avoid
context. We will test how PAAT choices are modulated by a combination of task variables (e.g., rewarding and
aversive outcomes), neural activity across OCDnet nodes, and OCD symptom severity. Preliminary results
show that the HDDM captures expected differences in choice dynamics (e.g., choice bias) between patients
and healthy controls. To quantify task-related functional interactions across this circuit, we will use ancestral
graph models, which measure the strength and direction of information flow across graph nodes. We will use
this combination of modeling approaches to test for changes in decision and circuit dynamics resulting from
targeted interventions (e.g., lesions, stimulation, treatment). Machine learning methods will quantify the degree
to which such quantitative model fitting improves (1) classification of patient condition and (2) our ability to map
changes in behavior, circuit dynamics, and disease course following interventions. Building on our extensive
experience in neural networks and levels of computation involved in motivated learning and decision making
across species, our computational framework will facilitate not only enhanced sensitivity to discriminate
between clinical conditions, but will also identify hypotheses about the likely mechanisms involved, which will
be tested via causal manipulations using the same quantitative framework. Contribution to Overall Center
Goals & Interactions with Other Center Components. Our modeling framework will be applied to data across all
Projects, including measures of connectivity (P1), behavioral and neural activity (P2-5), clinical measures (P3-
5), and influences of neural (P2&5) and behavioral (P4) interventions. Cores B & C will help with localization
and estimation of neural activity. We will benefit from interactions amongst experts with complementary
expertise in systems and cognitive neuroscience, psychiatry, engineering, and computational modeling.